Imaging, Histology and Functional Diagnostics Core

Summary/Abstract
The broad goals of this Core are to provide facilities for vision scientists at Columbia University. Resources are
provided for imaging, histology and electroretinographic recording. The module is administered so as to ensure
equipment access, technical support and personnel training. The availability of shared state-of-the-art equipment
and facilities operated by trained and highly qualified technicians with oversight by vision faculty substantially
increases the quality and quantity of achievements earned by research programs. Productive functioning of
these core facilities will i) facilitate collaborative efforts; ii) enable the tackling of gaps in our knowledge that
require multiple areas of expertise; enhance the productivity of ongoing research making research funds more
profitable; and enable the development of new research strategies. The clustering of clinically applicable
instruments with in the Core enhances interactions between research and clinical faculty and encourages
translational research. The availability of the resources of the Core is also an advantage when recruiting new
faculty.
The core provides training for students and postdoctoral associates in in vivo eye imaging using modalities of
short-wavelength fundus autofluorescence, near-infrared fundus autofluorescence and optical coherence
tomography (OCT). Training in tissue processing and sectioning for histological analysis is also made available
as is training in electroretinographic (ERG) recording of visual function.
The Core supports a clinical grade animal-dedicated confocal laser scanning ophthalmoscope (Heidelberg)
equipped for short-wavelength fundus autofluorescence (AF), near-infrared fundus autofluorescence,
angiography and spectral domain optical coherence tomography (SD-OCT). Two new high resolution Bioptigen
SD-OCT (Envisu R2210 and R4310) enable non-contact in vivo SD-OCT imaging of the eye in animal models.
This capability will advance investigations of cornea, tear film, lens, glaucoma and retinal structure in both the
diseased and healthy eye. The instruments enable the study of animal models of disease in parallel with human
subjects research.
The core maintains 3 instruments for ERG testing. These machines are used to test the function of retinal
pigment epithelium (bleach protocol, c-wave), photoreceptors (scotopic and photopic serial intensities), and
retinal ganglion cells in rodents.
Skilled personnel under the direction of Dr. Sparrow manage day to day activities including training in the use of
the instruments. Reserving and tracking of usage time and scheduling of maintenance together with other day-
to-day activities are managed by iLAB software.